Mechanisms of human RNA turnover and quality control

Project Summary/Abstract
RNA quality control pathways play essential roles in ridding cells of defective RNAs that
arise from RNA damage, misprocessing, or transcription of pseudogenes. Much has been
learned over the past decades about the quality control pathways that monitor the integrity of
protein-coding messenger (m)RNAs, such as the nonsense-mediated mRNA decay pathway.
Much less is known about those quality control pathways that monitor non-coding (nc)RNAs,
which make up ≈95% of the cell's RNA and are susceptible to the same types of damage as
mRNAs. The primary goal of this research is to uncover the mechanisms whereby ncRNA
quality control pathways distinguish normal from defective RNAs, how the defective RNAs are
targeted for degradation, and what are the consequence of failures in these pathways to cell
function and human health.
To address these questions we will over the next five years focus on the quality control
of abundant human stable small ncRNAs that are critical to cell function, including small nuclear
(sn)RNAs of the spliceosome and 7SL RNA of the signal recognition particle. We will take
advantage of the fact that 1,000s of pseudogenes of these RNAs exist in the human genome,
many of which produce defective ncRNA variants that must be detected and degraded by
quality control pathways. The features of these defective ncRNAs that are identified by quality
control pathways and the factors involved in their degradation will be uncovered through
targeted and global assays monitoring effects of degradation factor depletion and ncRNA
mutagenesis on the stability of the ncRNA variants. We recently uncovered a central role for 3'
end-processing machineries in one such quality control pathway that targets defective snRNAs,
and will therefore additionally over the next five years pursue RNA targets and potential roles in
RNA quality control of 3' end processing factors, including factors that when defective cause
human neurodegenerative disorders.
These efforts should uncover principles by which defective human small ncRNAs are
detected and degraded by quality control pathways, a mostly unexplored yet critical aspect of
gene expression. These efforts also have the potential to provide insights into defects in RNA
processing that lead to human disease such as neurodegenerative disorders.

Public health relevance
Project Narrative Uncorrupted gene expression is critical to cell function and human health. Our cells encode a multitude of RNA quality control machineries that detect and degrade defective RNAs that have the potential to interrupt gene expression, some of which have been linked to neurodegenerative disorders. The objective of this proposal is to uncover the mechanisms whereby these pathways detect and degrade defective RNAs in human cells, and the consequences of defects in these pathways to cell function and human health.